Core B: Biostatistics and Bioinformatics

PROJECT SUMMARY/ABSTRACT
Biostatistics & Bioinformatics: Core B
This core provides centralized services to the program project in three related areas:
biostatistics/bioinformatics, research computing, and data collection. The biostatisticians collaborate in all
phases of research from study design, through interim analysis and monitoring, to final analysis and
manuscript preparation. Biostatisticians were co-authors on over 81 manuscripts funded by this program
project during the previous funding period and are integral parts of the protocol development and review
process. The computing group is responsible for the maintenance and operation of shared computing
systems. These include a cluster of Itanium machines that support a centralized patient database, known as
Gateway, and a Sun workstation that supports statistical computing. The computing staff will create and
maintain entry and reporting programs for Gateway, assist others in data extraction from the database, and
maintain electronic connections to laboratory information which is downloaded directly to Gateway. The data
collection group is responsible for data abstraction and entry into Gateway, and for maintenance of archival
research files, which are stored in a web-accessible optical image library (OWL). The staff will follow an
explicit protocol for data abstraction, coding, key entry, and quality control that is applied uniformly to all
recipients entering research protocols within the Clinical Research Division, including protocols supported by
this program project.

Public health relevance
PROJECT NARRATIVE Biostatistics & Bioinformatics: Core B The activities of this core involve collaboration with each project and each core in the design and biostatistical analysis of all studies support by this program project, including observational studies and clinical trials. The core also supports the collection of data from patients enrolled in the associated clinical trials, and makes these data and data required for observational studies available in a relational database. The core also supports projects and other cores with the bioinformatics required for appropriate studies.